A statistical framework for disease classification with scRNA-Seq data

Project Summary
Background Single-cell sequencing data has enormous potential to improve our understanding of
human health, with direct applications in the areas of diagnosis and therapeutic selection. Single-
cell sequencing of mRNA expression levels (scRNA-Seq) initially focused on understanding fun-
damental biological systems at the single-cell level, but there is an increasing emphasis on using
scRNA-Seq to understand the role of single-cell variability on human health outcomes. While the
exploration of single-cell human variability and its relationship to disease is advancing, the cor-
responding statistical methodology to handle this type of data at the human population level lags
behind.
Project Objectives Broadly, the long-term goal of this proposal is a coherent methodological
framework for the analysis of the effect of single-cell variability on patient phenotypes. This pro-
posal considers the setting of population scRNA-Seq studies, where scRNA-Seq data is collected
from many patients representing populations with differing health outcomes. The proposed re-
search consists of the development and evaluation of statistical methodologies for these kinds of
scRNA-Seq population studies. The methodology developed by this proposal will ﬁll a critical gap,
helping to unlock the potential of scRNA-Seq data for improving human health.
Project Methods The proposed research program focuses on three speciﬁc aims that target the
most common analysis needs in scRNA-Seq population studies. Aim 1: Patient-level represen-
tation for scRNA-Seq data. This Aim will develop a summary representation of the scRNA-Seq
proﬁle of a patient and create statistical methods that allow comparisons of this summary proﬁle
between different patient populations. Aim 2: Predicting patient phenotypes based on scRNA-Seq
data. This aim will develop models that can predict health phenotypes based on the scRNA-Seq
measurements on a patient. Aim 3: Identifying cell-level and gene-level biomarkers for patient phe-
notypes. The methods developed in this aim will allow for identifying genes and cell populations
that differ at the single-cell level between patient populations. The biomarkers identiﬁed from these
methods will generate testable hypotheses for future exploration of the mechanistic relationship
between single-cell variability and patient outcome.

Public health relevance
Project narrative Understanding differences between human populations at the level of individual cells has the po- tential to improve our understanding of human health, with direct applications in the areas of diagnosis and therapeutics. While the exploration of human variability at the single-cell level is rapidly advancing, the corresponding statistical methodology to analyze this data when collected from a heterogeneous human population lags behind. This project will create a coherent statistical framework for determining the effect of single-cell variability on patient health; the methods will be implemented in open-source software that researchers can use in their studies to ﬁnd predictors of human health outcomes at the single-cell level.